Validation of a CD206-targeted PET imaging probe for pulmonary fibrosis

Idiopathic pulmonary fibrosis (IPF) is a chronic and progressive disease with limited treatment
options, poor prognosis, and a median survival of only 3-4 years after diagnosis. Current clinical
diagnostic techniques are limited in early detection, patient stratification, and treatment effect
monitoring. Invasive biopsy remains the gold standard to obtain pathological information for IPF
diagnosis and prognosis. Pulmonary macrophages, including alveolar macrophages and
monocyte-derived macrophages, are essential to the innate immune response in the
pathogenesis of IPF. CD206-positive (CD206+) macrophages have been found to be pro-fibrotic
and secret pro-fibrotic cytokines, interact with and support myofibroblasts, and promote
extracellular matrix (ECM) accumulation. Elevated CD206 expression has been found during
the fibrotic stage in bleomycin-induced mouse models and in the alveolar macrophages of IPF
patients. Therefore, CD206+ macrophages have emerged as a promising target for both
diagnostic and therapeutic interventions. However, current imaging agents targeting CD206,
either use single-mannose based agents that are not specific or nanobody/antibody-based PET
probes that might cause prolonged exposure to radiation or undesired pathologic effects to the
lungs. We have developed CD206-targeted MRI agents and demonstrated that they are specific
and able to map CD206+ macrophage changes in cutaneous injury, glioma, and stroke.
Histopathological studies showed that the fluorescent analog of the MRI agent correlates well
with CD206 and collagen and is markedly increased at week 3 compared to week 1 in
bleomycin-induced lung fibrosis. However, MRI is often unsuitable for imaging pulmonary
diseases, especially in ventilated patients. The goal of this proposal is to validate a PET imaging
probe that shares the specific binding moiety with the CD206-targeted MRI agent to track
CD206+ macrophages in pulmonary fibrosis. We will validate the specificity and efficacy of the
probe both in vitro and in vivo, in a bleomycin-induced mouse model of lung fibrosis. We will
demonstrate the ability of the validated probe in detecting CD206+ macrophages and correlate
imaging data with biochemical, flow cytometric, and immunopathological findings. The results
from this proposal will provide critical preliminary data for a forthcoming R01 application.

Public health relevance
Mannose receptor-positive (CD206+) macrophages play key roles in the pathogenesis of idiopathic pulmonary fibrosis (IPF) and have become a promising diagnostic and therapeutic target. The goal of this proposal is to validate a small-molecule based PET imaging probe to noninvasively and specifically detect CD206+ macrophages and validate the specificity and efficacy of the probe in a rodent model of bleomycin-induced lung fibrosis.